Cryo-EM of Helical Protein and Nucleoprotein Polymers at Near Atomic Resolution

Abstract
Supplementary funds are requested to purchase a glow discharge apparatus to be used nearly daily for the
projects funded by this R35. Glow discharge of EM grids is needed for both negative stain and cryo-EM
applications to clean the grids and make them more hydrophilic. This is a very important step in sample
preparation, and is crucial to getting good ice for cryo-EM. The existing apparatus was purchased in my lab ~
13 years ago, is failing to function properly, and cannot be repaired in any cost-effective way.

Public health relevance
Narrative This project is aimed at understanding the structure and function of a large number of helical protein and nucleoprotein filaments, ranging from actin in human muscle to helical viruses that infect organisms living in nearly boiling acid. Some of the studies are likely to have a direct and immediate impact on human health, such as those involving the bacteria responsible for meningitis and food poisoning, while others will have longer range impact including new tools for biotechnology.